sxRNA-Select: Using RNAs for Positive Selection of Cell Lines, Enabling High-Yield Biotherapeutic Production

Abstract - sxRNA Technologies, Inc (sxRNA Tech) is developing a rapid cloning technology, sxRNA-
Select, that will decrease the time it takes to clone mammalian cells and increase the protein yields
thereof. Biologics have emerged as a powerful and impactful class of therapeutics but are time-consuming and
expensive to develop and produce, with a major bottleneck created by the cloning selection process. Cell-line
development requires screening hundreds to thousands of clones. Current methodologies for selecting cells that
have stably incorporated genes of interest (GOIs) use antibiotic and/or metabolic selection approaches, which
are multi-phased and time-consuming. The very expression of these proxy proteins expends significant cellular
resources which can slow proliferation and limit total protein yield. Additionally, toxic selection agents must be
maintained throughout the selection process, further slowing growth, and causing the need for a processing step
to remove them which risks cell line stability and productivity. The aim of this STTR program is to develop a plug-
and-play structurally interacting RNA (sxRNA) cloning kit that reduces time to cell line selection while increasing
protein yield. Selection is controlled using sxRNA, an RNA-based technology that enables specific
selection based on the unique expression of an RNA expressed as part of the GOI being cloned. sxRNA-
Select uses the production of a microRNA (the trigger) imbedded into a GOI intron. The expressed trigger then
interacts with a co- and/or subsequently-transfected transient mRNA (the sxRNA-bait), modulating its translation.
The trans-interaction of the sxRNA-trigger with the mRNA/sxRNA-bait is used to analogically select cells
expressing the GOI the most and can be used as a proxy for GOI expression level. Critically, because the
mRNA/sxRNA-bait degrades within days, high producing stable clones do not waste valuable cellular resources
on maintaining the production of a selectable marker. The company previously developed the sxRNA technology
as a tool for use in cell culture applications. Main areas of technical risk center around the efficacy of
simultaneous and/or subsequent transfection of plasmids and sxRNA-bait, effective ratiometric protein
production, and directly demonstrating the time and yield advantage of the approach compared to state-of-the-
art methods available to therapeutic developers today. For this Phase I project, sxRNA, in collaboration with the
University at Albany-SUNY, will undertake three specific aims: 1) optimizing the protocol for delivery of plasmids
and sxRNA-bait, 2) demonstrating selection for ratiometric protein expression, and 3) conducting a head-to-head
yield comparison with industry-standard approaches including metabolic and antibiotic selection. At the
conclusion of this work, sxRNA Tech will have a minimum viable product for rapid cell cloning based on positive
selection with sxRNAs. Phase II will then focus on the combination of positive selection and negative selection,
the relatively simpler process. Further development will include the expression of even more complex trispecifics
and a scale-up of the manufacturing process to ensure that demand can be met once commercialized.

Public health relevance
Narrative - Biologics have emerged as a powerful and impactful class of therapeutics but are time-consuming and expensive to develop and produce with a major contributing factor derived from the cloning selection process. This project will develop a plug-and-play structurally interacting RNA (sxRNA) cloning kit, sxRNA- Select, that reduces time to cell line selection while increasing protein yield. Selection is controlled using sxRNA, an RNA-based technology that enables specific selection based on the unique expression of an RNA expressed as part of the gene of interest being cloned.